Influence of Age and Sex on Cerebral Edema Formation Following Traumatic Brain Injury

Traumatic brain injury (TBI) is a serious public health concern. After TBI, elderly patients suffer from higher
mortality rate and worse functional outcome compared to young patients. A further complication in the treatment
of TBI occurs due to lack of clear knowledge on sex differences in TBI. The influence of biological age and sex
on the outcomes of TBI is an important but understudied area of research and one of the major reasons for the
limited success observed in several TBI-related clinical trials is, attributed to their failure to account for critical
sex and age-related differences in disease expression. Considering this gap in knowledge, the major goal of our
proposal is to conduct a pre-clinical study that focuses on the influence of age and sex in TBI. One of the most
devastating clinical symptoms of TBI is the formation of cerebral edema leading to an increase in intracranial
pressure that impairs cerebral perfusion and oxygenation, and contributes to additional ischemic injuries.
Maintaining integrity of the blood-brain barrier (BBB), the protective barrier of the brain, and the prevention of
the leakage of fluid and proteins from small blood vessels to the extravascular space (microvascular
hyperpermeability) are critical to preventing and treating brain vasogenic edema. We propose a novel paradigm
of age and sex dependent changes in microvascular hyperpermeability following TBI, and evaluate if an
inflammatory-mediated signaling mechanism responsible for this hyperpermeability is age and sex dependent.
Our overarching goal is to understand how age and sex of an individual differentially influence vascular
permeability and leading to cerebral edema formation following TBI and ultimately develop new and effective
therapeutics for head trauma patients of all ages/sex. In this proposal, we will investigate how age and sex
differentially control microvascular permeability and molecular pathways that lead to activation of Neutrophil
Extracellular Traps (NET) and NLRP3 inflammasome signaling resulting in vascular hyperpermeability, following
TBI and how age and sex influence this pathway. Our central hypothesis is that age/sex differentially influence
microvascular permeability, cerebral fluid dynamics and outcomes of TBI, in an NET/NLRP3 inflammasome-
dependent manner. Increased NET formation that occurs following TBI promotes NLRP3 inflammasome-
mediated endothelial tight junction (TJ) breakdown, hyperpermeability and cerebral edema formation in an age
and sex dependent manner. Our specific aims are to: 1) Determine the influence of age and sex on microvascular
hyperpermeability following TBI; 2) Determine the upstream regulators of microvascular hyperpermeability
following TBI and the influence of age and sex. The proposed novel, integrated approach capitalizes on a refined
and relevant mouse model of TBI combined with intravital microscopic imaging of microcirculation, thin-section
and feeze-fracture electron microscopy of tight junctions, analysis of cerebral fluid dynamics and cellular and
molecular biology approaches. Understanding these novel principles will help us find new ways to treat and
prevent cerebral edema in head trauma patients in the future, irrespective of their age and sex.

Public health relevance
NARRATIVE: Traumatic brain injury is a serious public health concern and the incidence of elderly TBI has doubled in the past twenty years. A further complication in the treatment of TBI occurs due to lack of clear knowledge on sex differences in TBI. This proposal is to understand the influence of age and sex on brain swelling, one of the most devastating symptoms of TBI, and to delineate the underlying mechanisms.